Research Expanding Access to Child Health (REACH)

PROJECT SUMMARY
The overall goal of this Center of Biomedical Research Excellence (COBRE) is to strengthen pediatric health
care research infrastructure in Delaware, specifically that at the Alfred I. duPont Hospital for Children. Consistent
with this goal, we will establish a thematic, multidisciplinary health research system – The REACH (Research
Expanding Access to Child Health) Center – rooted in the principles and methods of pediatric healthcare delivery
science, bridging our biomedical research and health care systems, and focused on ensuring equitable access
to high quality pediatric health care for all. The mission of the Administrative Core is to coordinate the people
and processes needed to establish REACH as a Center of Biomedical Research Excellence, implement the
Center’s plans, and ensure achievement of the Overall Specific Aims. The REACH Center Administrative Core
aligns all elements for accomplishing the Overall Aims of the Center. The Administrative Core has prioritized five
key functions: 1) stewardship; 2) creation of resources; 3) allocation of funds and resources; 4) production,
synthesis, and utilization of research; and, 5) accountability and sustainability. These functions will be
accomplished through the purposeful implementation of three Programs (Project Funding, Mentorship, and
Research Management) and the coordination and integration of two REACH Center Research Cores –
PROMISE (Pediatric Research Optimizing Methods in Stakeholder Engagement) and IMPACT (Intervention
Methods: Provision and Connection through Technology) – with existing Delaware IDeA state network resources.
With an exceptional project team and sound governance plan, the Administrative Core will: 1) create a cohesive
sustainable infrastructure to expand capacity for innovative stakeholder-engaged research programs developing
and evaluating technology-enabled interventions to address inequities in child health; 2) coordinate educational
and administrative resources to establish a critical mass of independent multidisciplinary investigators committed
to research addressing issues of equity in pediatric healthcare; and, 3) ensure successful day-to-day operations
and long-term success of the REACH Center. The Administrative Core will provide an integrated network of core
resources, project funding, a robust mentoring program, and expert research operations and administrative
oversight to build biomedical research excellence in Delaware focused on expanding access to high quality
pediatric health care and health for all children in Delaware with broad national implications.